Administrative Core

The goal of the Administrative Core Is to maintain and enhance an organization that coordinates and Integrates Center activities, attracts new Investigators of outstanding ability to environmental health sciences (EHS), contributes to career development, facilitates interdisciplinary activity, creates and promotes new cutting-edge research opportunities, and provides a two-way avenue of community interaction.